COBRE CORE C: TRANSGENIC MICE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this core is to develop, maintain, and interbreed the multiple transgenic mouse strains on the appropriate genetic backgrounds and to provide these mice as required for experiments by the COBRE projects.